PROSTATE CANCER PROGRAM

The Prostate Cancer Program comprises 24 basic and clinical scientists from several disciplines, including 9 Departments working together to translate research into advances in the epidemiology, prevention, staging and treatment of prostate cancer. Program faculty represent membership in 4 graduate programs: PIBS, BMS, Bioengineering, and Chemical Biology. The goals of the Prostate Cancer program are to promote interdisciplinary research that will allow a better understanding of the biology of prostate cancer, from the biologic and environmental factors associated with carcinogenesis, early detection and disease progression to prognostication and the biologic basis of disease progression. The ultimate goal is the development of novel intervention strategies that will improve the lives of men who carry a diagnosis of prostate cancer or who are at risk of developing prostate cancer. The Prostate Cancer Program pursues these goals through ongoing work in five major thematic areas: (1) Prostate Cancer Epidemiology; (2) Imaging and Risk Assessment Strategies; (3) Genetics and Biology of Cancer Progression; (4) Outcomes Research, Health Resource Utilization and Medical Decision Making; and (5) Novel Therapeutic Targets and Approaches. The Program has $7,248,631 Total peer reviewed support for the last budget year. The Program has 26% intraprogrammatic and 23% inter-programmatic publications.